Academic-Industrial Partnership for Translation of Acoustic Angiography

PROJECT SUMMARY
Traditional grayscale ultrasound imaging is widely used in diagnostics because of its accessibility, low-cost,
portability, and safety. Ultrasound is the only modality which is getting smaller and less expensive, and thereby
more accessible to rural and underserved populations. Modern ultrasound systems can now be handheld and
cost ~ 1/1000th of an MRI system. However, the major challenge remains that ultrasound is poorly specific to
solid cancers. Techniques to improve the specificity and sensitivity of ultrasound to solid tumors would have a
significant impact in early detection and reduction of unnecessary biopsies, saving lives and reducing healthcare
costs. Our team is developing an innovative microvascular imaging technology, based on hardware advances in
multi-frequency ultrasound transducers, as well as signal processing techniques to specifically detect contrast
agents while reducing background noise. Preliminary data using the first generation of this technology has shown
substantial potential to improve our ability to differentiate cancerous lesions from healthy tissue, based on the
ability to resolve differences in angiogenic vasculature morphology from healthy tissue. This diversity supplement
will support Ms. Jadyn Cook’s career development and scientific training in biomedical engineering of ultrasound
tools to improve our detection of cancer. Her research focus relevant to the parent grant will focus on the
development and testing of dual-frequency ultrasound techniques.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project is a continuation of a collaboration which aims to develop new tools and approaches for imaging the microvasculature with ultrasound. Data suggests that imaging the microvasculature will provide us with an improved ability to detect and differentiate cancer in humans, and if successful, our approach may lead to a new low-cost, safe, portable imaging modality that is better at early detection of cancers than currently available modalities. To pursue this, we will develop new ultrasound hardware and imaging approaches, and test their performance in preclinical and clinical populations.